Animal Core

ANIMAL CORE - ABSTRACT
The Animal Core is the center’s most active scientific hub for catalyzing research on in vivo genetic
and environmental analysis for the pathogenesis of alcoholic liver and pancreatic diseases (ALPD)
pursued by investigators within and outside of the center. The core now generates 22 different
versions of the models including a newly developed mouse model of alcoholic hepatitis which utilizes
a hybrid feeding technique of ad lib consumption of Western diet and intragastric feeding of ethanol
diet plus weekly ethanol binge. The core also developed Western alcohol diet-based tumor-promotion
models for hepatocellular carcinoma (HCC) and pancreatic adenocarcinoma (PDAC); alcohol-
mediated tumorigenesis by orthotopic transplantation of liver tumor-initiated stem cell-like cells (TICs),
patient-derived xenograft (PDX) models for HCC or PDAC, and the mouse with humanized liver cells
and immune cells to support translational research.
During the current cycle, the Core provided 4,075 mouse models to 30 center and 13 non-center
investigators, resulting in 85 publications of which 46 are collaborative papers. The Core’s support
facilitated 41 grants acquired and 21 applications submitted by the center members, and 21 grants
and 8 applications by 22 non-center investigators. In addition, the Core’s tissue sharing program has
provided 555 samples to 27 investigators from 19 institutions across the nation to support their
respective alcohol research.
In the next cycle, the core will pursue the following specific aims to fulfill its mission of serving the
nation for promotion of research on ALPD and cirrhosis:
1. To serve as a national resource by provision of 21 different versions of rodent models which
recapitulate advanced and clinically relevant pathologic spectra of ALPD and cirrhosis.
2. To have the PDX and humanized mouse models available as widely available services.
3. To support in vivo genetic analysis and cell fate mapping analysis by utilizing genetic models.
4. To promote cell type specific research via close collaboration with the center’s Integrative Liver
Cell Core for better elucidation of cell fate regulation underlying ALPD spectra.
5. To render full support to early-stage scientists, including those funded by the Pilot Project Core to
maximize their potential for a successful transition to independent investigators.
6. To stimulate collaboration and synergize productivity via shared use of the models and tissues.
7. To continue developing new models of ALPD by combining genetic and environmental risk factors.